Research Training in Nephrology

Project Summary / Abstract
This proposal requests support for the continuation of a research training program in
academic nephrology, under the directorship of Dr. Martin Pollak, Chief, Nephrology
Division, Beth Israel Deaconess Medical Center (BIDMC) and Professor of Medicine,
Harvard Medical School (HMS). Support is requested for five trainees who will typically
spend at least two years in the training program. As in the past, we expect that most
candidates will have received the MD degree or the MD-PhD degree prior to entry but
prospective trainees with a PhD and a background in a relevant scientific discipline are
also considered. The major criterion for selection is evidence of an interest, ability and
commitment for a career in investigative nephrology. Research activities span basic and
translational investigations. Current research areas include acute renal failure,
mechanisms of cell injury and cell metabolism, ion transport and water excretion, cellular
transduction mechanisms, preeclampsia, glomerular pathology, genetics of kidney
disease, cellular and transplant immunology, gene regulation, genomics and proteomics
of the kidney, angiogenesis, vascular leak, diabetic nephropathy, metabolism, and
epidemiology. The chief method of instruction is intensive personal involvement in a
research program under the close supervision of an experienced mentor. Participation in
a structured program of career mentoring, research seminars, journal clubs, and
laboratory presentations is mandatory for all trainees. The primary facility for training is
the Nephrology Division at BIDMC, with additional training sites in the Transplant,
Rheumatology, and Cardiology Divisions at Children's Hospital Boston, the Dept. of
Medicine (Renal Division) at Brigham and Women's Hospital, the Wyss Institute, the
Broad Institute, and the Renal Unit at Massachusetts General Hospital. A variety of core
facilities (animal, genetics, imaging, biochemical, etc.) are available at BIDMC and/or
Harvard Medical School, the Harvard CTSA, and at the other training sites. These sites
are close to each other, facilitating interactions.

Public health relevance
8. Project Narrative There is a well-recognized growing need to educate physician and PhD scientists for research careers in nephrology. This program offers a rigorous training experience to physicians not previously trained in research and to those with PhD degrees who wish to obtain postdoctoral training in kidney-related science. The increasing societal burden of kidney diseases, coupled with a continued nationwide difficulty in attracting physician-scientists to internal medicine in general, and to nephrology in particular, reinforces the public health importance of this program.